A novel role for E2fs: E2f7 and E2f8 control motile ciliogenesis

ABSTRACT
Multiciliated cells (MCCs) occur in airways, ependyma and oviduct and are crucial for respiration, neurogenesis
and fertility. MCCs nucleate up to 300 motile cilia at their apical surface to generate directional fluid flow. Res-
piratory MCCs are responsible for constantly cleaning airways from inhaled pollutants and pathogens to maintain
pulmonary health (mucociliary clearance). Notably, airway ciliated cells are the primary targets for human SARS-
CoV-2 infections, and impaired clearance by defective MCCs, acquired or inherited as genetic ciliopathies, is
associated with chronic airway infections, COPD and asthma. Motile ciliogenesis is directed by > 600 ciliary
genes via sequential and hierarchically organized activity of MCC transcription factors. However, transcriptional
regulation of multiciliogenesis is only partly deciphered, with major knowledge gaps in the early phases of differ-
entiation which establish MCC fate and orchestrate centriolar amplification. E2f transcription factors, evolution-
arily conserved from plants to mammals, are major regulators of cell cycle. The canonical E2f1-6 regulate ex-
pression of genes controlling DNA replication and the mitotic machinery. In contrast, only a few physiological
scenarios are known where the atypical repressors E2f7 and E2f8 are essential. We recently identified an unex-
pected major new role of E2f7 and E2f8 in motile multiciliogenesis of airways, ependyma and oviducts. We
find E2f7 and E2f8 exclusively expressed in two cell populations of airway epithelium, the cycling basal and the
earliest MCCs progenitors. Notably, ablation of E2f7 in mice causes a profound reduction in basal bodies and
cilia numbers in airways, ependyma and oviduct. Additional loss of E2f8 further exacerbates the phenotype,
indicating physiological cooperation. We will test our hypothesis that E2f7 and E2f8 act as the switch from
proliferating uncommitted progenitors to differentiating MCC progenitors which fundamentally requires overcom-
ing the strict once-per-cell-cycle centriole duplication program of dividing cells. We postulate that E2f7 and E2f78
are critical for decoupling centrosome duplication from cell division. E2f7 and E2f78 achieve this by cooperatively
blocking DNA replication and inducing the alternate S*/G2M*-like phases which enables centriolar biogenesis.
This is followed by mainly E2f7 regulating and balancing the early MCC transcriptional program, thereby safe-
guarding centriolar multiplication. This proposal will comprehensively and systematically identify mechanisms,
molecular partners and their place in the transcriptional MCC hierarchy that underlie this new ciliary function of
E2f7/f8. Aim 1 performs single cell mechanistic and functional analyses of E2f7 and E2f8 in MCCs in primary
organotypic cultures. Aim 2 maps E2f7 and E2f8 within the MCC hierarchy and the alternate cell cycle in early
ciliogenesis. Aim 3 identifies the proximal functional protein interactome of E2f7 and E2f8 in multiciliogenesis
with functional validation. The results will greatly expand our fundamental insights into motile multiciliogenesis
and lay the groundwork for identifying potentially causal roles of dysfunctional E2f7/f8 in cilia-related human
airway and lung diseases, crucial for developing novel therapeutic strategies for their prevention and treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE The airway epithelium is the crucial host defense against lung injury and infections. It plays a key role in the development of lung diseases and is an emerging target for new therapies. However, our understanding of how this important barrier is fundamentally regulated is limited. Thus, it is paramount to identify new key regulators of this tissue. Multiciliated cells (MCCs), critical within this epithelium, nucleate up to 300 motile cilia at their apical surface to generate directional fluid flow which constantly cleans airways from inhaled pathogens, pollutants and dust to maintain pulmonary health (mucociliary clearance). Notably, airway ciliated cells are the primary targets of human SARS-CoV-2 infection. Moreover, impaired clearance by defective MCCs, either acquired or due to genetic ciliopathies, causes chronic airway infections and COPD and is associated with asthma. Our new studies produced compelling evidence that the E2f7 and E2f8 members of the E2f family of transcription factors have previously unknown essential roles in the early phases of multiciliogenesis. Moreover, human E2f7 and E2f8 are dysregulated in patients with asthma, fibrosing interstitial lung diseases and COPD. Furthermore, E2f7 and E2f8 directly regulate human primary ciliary dyskinesia-associated genes. The proposed research is relevant to public health because it will comprehensively define the essential role of E2f7 and E2f8 as master regulators of MCC differentiation, with the long-term goal to use this knowledge to design innovative therapies and diagnostic strategies for chronic airway diseases. This research is relevant to the mission of NHLBI pertaining to stimulating basic discoveries about airway diseases.